Dissecting mRNA-ribosome interaction in AU-rich transcriptome of Plasmodium falciparum

Project Summary/Abstract – from original application
Genome sequencing of P. falciparum, the causative agent of malaria, has laid the foundation for significant
biological advances by exposing surprising genomic information. The P. falciparum genome is extremely AT-
rich (~80%) and comprised of a large number of genes encoding polyadenosine (polyA) tracks. In most
eukaryotes, including humans, polyA tracks act as negative regulators of gene expression. Our recent studies
have shown that the translation of mRNAs containing polyA track motifs results in ribosomal stalling and
frameshifting in the majority of eukaryotic and bacterial organisms. In contrast to most organisms, P. falciparum
can efficiently and accurately translate polyA tracks. Therefore, we want to understand how P. falciparum can
effectively translate these genes. We hypothesize that potential contributors to P. falciparum’s unique translation
mechanism are RNA-binding proteins, variations in the translation quality control machinery, and adaptations to
the ribosomal RNA (rRNA) itself. P. falciparum evolutionary adaptation towards an AT-rich genome and polyA
encoded lysine stretches remains to be explored. We first want to identify proteins in P. falciparum that bind to
mRNAs containing polyA tracks or stalling sequences and determine the components of the no-go decay mRNA
surveillance mechanism within the parasite (Aim 1). By understanding this process, we will begin to understand
the fundamental differences between Plasmodium translation and all other characterized eukaryotes. We will
use an adapted mRNA tagged system to pull-down mRNAs and examine the proteins binding to these mRNAs
in P. falciparum cells (Aim 1a). We also hypothesize that to have an efficient translation of polyA track genes;
there must be a unique relationship between mRNA-containing polyA tracks, ribosomes, and mRNA surveillance
mechanisms in malaria parasites (Aim 1b). We will analyze features of P. falciparum rRNA involved in polyA
translational fidelity and poly-lysine synthesis in vivo (Aim 2). We will use the MS2-tagged ribosome system
adapted for P. falciparum rRNAs and ribosome isolation (Aim 2a). Finally, we believe that PfRACK1 protein aids
in polyA track translation in Plasmodium cells. We will determine if PfRACK1 assists in polyA translation in both
plasmodium and human cell lines and will also examine the differential, stage-dependent ribosomal binding of
PfRACK1 within the parasite (Aim 2b). Association of PfRACK1 protein with P. falciparum and human ribosomes
and their interaction with polyA mRNAs will be further characterized using single-molecule fluorescence
resonance energy transfer (smFRET) The goals of this project are to characterize P. falciparum mRNA
surveillance system fully, and we will be among the first to study the translational complexities in the P. falciparum
genome. We believe that this information will be crucial to fighting malaria and that these unique features of the
parasite can be exploited into new therapeutic targets, thus furthering the battle against malaria.

Public health relevance
Project Narrative – from original application Plasmodium falciparum, a causative agent of human malaria, inflicts an enormous burden on global human health. Even though P. falciparum is a eukaryotic organism, there are vast differences in the mechanisms of mRNA translation and surveillance between P. falciparum and humans. This project will apply new approaches to understand better the evolution of the previously unexplored process of protein synthesis in the AT-rich genome of malaria parasites and exploit new parasite-specific drug targets.